Investigating the Asymmetrical Development of Ebf1+ Cells in the Central Amygdala and Its Functional Consequences

Project Summary
Brain asymmetry, a conserved feature of the vertebrate nervous system, is thought to be an advantageous
mechanism for efficient information processing. This asymmetry manifests in anatomical and molecular left-right
(L-R) differences that correlate with specialized functions in specific cognitive processes. Disruption of
asymmetry in multiple brain regions including the prefrontal lobe and the amygdala has been implicated in the
pathogenesis of several neurodevelopmental disorders, such as autism spectrum disorders. In mammals, brain
asymmetry has been demonstrated in multiple brain regions involved in regulating emotion processing and
memory, including the habenula, the hippocampus, the prefrontal cortex, and the amygdala. Our preliminary
single-cell RNA sequencing (scRNAseq) and in situ hybridization (ISH) analyses revealed a distinct, left-to-right
biphasic expression pattern of the early B cell factor gene, Ebf1, in the lateral ganglionic eminence (LGE)/striatum
and central amygdalar nucleus (CeA). Ebf1 expression displayed a predominant L-sided dominance in the
LGE/striatum and CeA before embryonic day 14 (E14), switching to R-sided dominance after E16 and persisting
into adulthood. Furthermore, our ISH data showed that Ebf1 primarily colocalizes with Drd1 in striatal and CeA
cells, suggesting a role for Ebf1+ cells in regulating the acquisition of contextual fear, Pavlovian conditioned fear
responses, and appetitive behaviors. In this proposed study, I aim to investigate the cellular and molecular
signatures of Ebf1 cells in the amygdala and determine whether these lateralized expression patterns have
functional consequences in regulating emotion-related behaviors. By forging a new path in this area of research,
our findings have the potential to significantly advance our understanding of neurodevelopmental disorders. To
achieve this goal, we have outlined three specific aims: 1) To trace the developmental origin of asymmetrical
Ebf1+ cells and their progenies in the L-R CeA. 2) To identify the cellular and molecular signatures of
asymmetrically distributed Ebf1+ cells and Ebf1 lineages in adult CeA. 3) To investigate how asymmetrical Ebf1+
cells contribute to CeA-dependent emotion behaviors. This study will address the following key questions: When
do the asymmetric L-R Ebf1 cells develop in the CeA? What are the functional properties of CeA-Ebf1 cells?
How do these unilaterally distributed Ebf1 cells contribute to behavioral asymmetry? By elucidating these
questions, this study will serve as a proof-of-principle, paving the way for a deeper understanding of brain
asymmetry and its potential role in neurodevelopmental disorders.

Public health relevance
Project Narrative In this study, we're interested in examining the building blocks of specific brain cells in an area that controls emotions. These cells function differently on the left and right sides of the brain. We want to see if these differences influence emotion behaviors.